IP21-002 US Enhanced Surveillance Network to Assess Burden, Natural History, and Effectiveness of Vaccines to Prevent Enteric and Respiratory Viruses in Children

PROJECT SUMMARY ABSTRACT- MANDATORY CORE
The purpose for Mandatory Core Component A is to support an Enhanced Surveillance Network of US
pediatric institutions to develop and implement standard research protocols to conduct prospective active
population-based surveillance in defined inpatient and emergency department (ED) settings for a) acute
gastroenteritis (AGE) due to norovirus, rotavirus and other enteric pathogens, b) acute respiratory infection
(ARI) due to respiratory viruses including influenza, RSV, parainfluenza viruses, human metapneumovirus,
rhinoviruses, enteroviruses (including EV-D68), adenoviruses, coronaviruses (including SARS-CoV-2) and
other respiratory viruses, c) and healthy controls (HC) and d) Acute Flaccid Myelitis (AFM) syndrome among
pediatric patients seeking healthcare at these pediatric medical institutions. The results from this program will
be used to inform vaccine recommendations and assess the public health impact of the US rotavirus, influenza
and SARS-CoV-2 vaccination programs and provide epidemiologic data for other infectious diseases with
therapeutics and vaccines in development. There are two objectives for Mandatory Core Component A::
For Objective 1 we will conduct population-based active surveillance for respiratory and enteric viral pathogens
in pediatric inpatient and ED settings and enroll asymptomatic healthy controls in Hamilton Co. children <18
years of age. Through our already established ARI, AGE and HC Surveillance Platforms we will 1) perform
active surveillance to determine the etiology and burden of inpatient and ED acute viral enteric and respiratory
diseases in our defined population, 2) characterize the clinical and epidemiologic factors of infections including
asymptomatic children and 3) evaluate VE and impact of vaccines and other interventions available or projected
to become available during the study agreement period for rotavirus and influenza vaccines using a test-
negative design and for RSV and SARS-CoV-2, when available and recommended for children and
adolescents. For Objective 2 we will conduct surveillance activities for acute flaccid myelitis (AFM in
hospitalized children <18 years of age). Through our already established AFM Surveillance Platform, we will 1)
define baseline rates of AFM in our pediatric institution through active case finding in collaboration with our
Neurology and Neuroradiology Co-Investigators using the CDC's case definition for patients meeting the clinical
criterion for AFM and a spinal MRI showing at least some gray matter involvement by conducting active
surveillance and establishing incident rates for AFM among hospitalized children within our catchment area, 2)
compare rates of AFM to rates of circulating respiratory and enteric pathogens at our site from our population-
based active surveillance program and 3) characterize the clinical spectrum of pediatric AFM and compare with
the clinical spectrum seen with other similar neurologic conditions.

Public health relevance
PROJECT NARRATIVE ENHANCED SURVEILLANCE NETWORK (ESN) MANDATORY CORE The Enhanced Surveillance Network (ESN) will provide a national network of pediatric inpatient, emergency department and outpatient surveillance sites to advance the health of children by determining the disease burden and epidemiology of enteric and respiratory viruses including rotavirus, norovirus, influenza, RSV, parainfluenza viruses, human metapneumoviruses, rhinoviruses, enteroviruses (including EV-D68), adenoviruses and coronaviruses (including SARS-CoV-2). Within the framework of this network the impact of the US Rotavirus, Influenza and SARS-CoV-2 Immunization Programs will be monitored by assessing the effectiveness of these vaccines and examining the impact on the epidemiology of these diseases pre- and post-licensure. The ESN will also conduct surveillance for acute flaccid myelitis and multisystem inflammatory syndrome in children (MIS-C) to determine the incidence, clinical features and risk factors for these conditions.